Improving Pediatric Brain Injury Outcomes Through Equitable Care Implementation

Project Abstract
Pediatric traumatic brain injury (TBI) is a public health crisis in the U.S. and worldwide.
Adherence to the Brain Trauma Foundation Guidelines for the care of infants and children with
acute TBI improves pediatric TBI outcomes but does not address additional outcome
improvements that could be achieved by considering equity in acute TBI care. Addressing
disparities in acute TBI care represents an important unmet need. We leverage the availability
of the Pediatric Guideline Adherence and Outcomes (PEGASUS) program and ongoing
randomized controlled trial and propose a one-year project to achieve equitable acute pediatric
TBI care. The overarching aim is to incorporate an anti-racism lens to strengthen equitable
implementation of the PEGASUS program for use by Level I and Level II U.S. trauma centers.
The two Specific Aims are: 1) To characterize racial/ethnic disparities in acute pediatric TBI
care and 2) To identify barriers, facilitators, and strategies to achieving equitable acute pediatric
TBI care provision. An expected outcome of the proposed research is a PEGASUS equity
assessment toolkit that Level I and II trauma centers can use to improve equitable
implementation of the PEGASUS program in the United States.

Public health relevance
Project Narrative Adherence to the Brain Trauma Foundation Guidelines for the acute care of infants and children with traumatic brain injury (TBI) improves discharge outcomes but the guidelines do not address equitable implementation to improving outcomes. We will examine race/ethnicity disparities in acute pediatric TBI care and examine barriers and strategies to eliminate racial/ethnic disparities in the United States through an equity framework lens.